Determining the Effects of Food Insecurity and Psychosocial Stress on Racial and Ethnic Disparities in Prenatal Nutrition and Preterm Birth Risk

PROJECT SUMMARY
At odds with common assumptions — and hope, pregnancy ends in preterm birth (PTB) for approximately 1 in
10 women. Yearly PTB affects 15 million infants worldwide and 386,580 in the United States. PTB is the
leading cause of global, and U.S., neonatal mortality and morbidity and is associated with future risk for poor
physical (higher blood pressure, chronic kidney disease, wheeze/asthma) and mental (ADHD, IQ decrements)
health. Maternal health is not spared: women who deliver preterm are at an increased risk for depression,
hypertension, cardiovascular and renal disease later in life. In the U.S., the racial and ethnic disparities in PTB
rates are dramatic and independent of socio-economic status (SES): overall, 14.12% for Non-Hispanic Black
compared to 9.09% for Non-Hispanic White women. Psychosocial stress and childhood trauma each are
associated with risk for PTB. PTB has an intergenerational impact: mothers born preterm are more likely to
give birth preterm, especially amongst Black women. Literature proposing psychosocial and physiologic
pathways between maternal stress and PTB demonstrate significant differences in self-reported and biologic
markers of stress between non-Hispanic Black and White women. Racial and ethnic differences have also
been reported in dietary behaviors in response to acute stress and economic adversity from food insecurity.
We aim to identify nutritional profiles of pregnant women with food insecurity and psychosocial stress,
determine racial and ethnic differences in nutritional profiles by food insecurity and psychosocial stress
experiences, and evaluate whether nutritional profiles affect the pathway by which food- and psychosocial-
related stress contributes to increased risk for PTB among racial and ethnic minoritized women. In a sample of
post-attrition n=175 pregnant women we will test the following two aims: Aim 1: To determine whether there are
unique nutritional profiles (self-reported maternal dietary quality and serum 25-hydroxy Vitamin D level) of
pregnant women with food insecurity and psychosocial stress (anxiety, depression, perceived stress) that differ
by race and ethnicity. Aim 2: To evaluate if maternal prenatal nutrition mediates the association between food-
and psychosocial-related stress and earlier gestational age (GA) at birth and if this mediation is moderated by
race and ethnicity. This new conceptual framing of PTB that incorporates dietary intake and quality is
important to identify new biologic and behavioral mechanisms for PTB risk that will inform future interventions
that can reduce PTB and dietary disparities.

Public health relevance
PROJECT NARRATIVE Pregnancy ends in preterm birth (PTB) for approximately 1 in 10 women, though more often for Non-Hispanic Black women, with 14.12% PTB rate, compared to 9.09% for Non-Hispanic White women. Racial and ethnic differences have also been reported in dietary behaviors in response to stress and economic adversity such as food insecurity. In this project, we will identify nutritional profiles of pregnant women with food insecurity and psychosocial stress, determine racial and ethnic differences in nutritional profiles by food insecurity and psychosocial stress experiences, and evaluate whether nutritional profiles affect the pathway by which food- and psychosocial-related stress contributes to increased risk for PTB among racial and ethnic minoritized women.